Network Medicine for Alzheimers Disease: Functional Dissection and Pharmacologic Perturbation of a Human Brain Synaptic Regulatory Expression Signature

PROJECT SUMMARY
Analyses of transcriptomic profiles from human brains constitute a powerful strategy for highlighting biological
networks associated with Alzheimer’s disease (AD) pathophysiology. In collaboration with the Accelerating
Medicines Partnership (AMP)-AD Consortium, we have defined promising molecular networks dysregulated in
AD based on analyses of RNA-sequencing from ~2,000 human brain autopsy samples. In order to translate
these results for “network therapies”, computational predictions must be rigorously tested in experimental
animal models. In order to pinpoint causal drivers among AD-associated coexpression networks, 357
conserved targets were systematically screened using transgenic Drosophila, identifying 144 modifiers of
human amyloid-beta (Aß)- and/or tau-triggered neuronal dysfunction. Our results highlight a promising 167-
gene synaptic regulatory network (SRN) linked to glutamate excitatory signaling that is both (i) significantly
down-regulated in AD and (ii) enriched for suppressors of neurodegeneration based on knockdown in
Drosophila. Moreover, GRIN2B, an NMDA receptor subunit and target of the approved AD drug, memantine, is
a “hub” suppressor. We hypothesize that SRN represents a highly conserved and coordinated
transcriptional protective response that compensates for excitotoxic neuronal injury in AD, consistent
with evidence that hyperexcitability and impaired synaptic plasticity are important contributors to disease
pathogenesis and clinical manifestations. We propose here to deploy our powerful cross-species strategy to
refine this mechanistic hypothesis and develop a pharmacologic approach to boost SRN and thereby support
brain resilience in AD. First, (AIM1), we will perform systematic genetic manipulations to simulate up- or down-
regulation in hundreds of SRN genes and screen for enhancers and suppressors of tau- or Aß-induced, age-
dependent neuronal dysfunction. Promising hits will be validated using independent assays, and Mendelian
randomization will confirm the causal impact of SRN human gene expression changes on AD risk or protection.
Next (AIM2), we will perform genetic manipulations of GRIN2B and other identified SRN causal drivers in
Drosophila models of excitotoxic neuronal injury, along with complementary studies in mouse primary
hippocampal neuron cultures. Lastly (AIM3), we will experimentally probe fine-scale SRN architecture,
assaying transcriptional signatures following genetic perturbations of inferred nodal driver genes in both the
presence or absence of excitotoxicity and other AD pathologic triggers. We will then nominate small molecule
perturbagens for experimental validation in human neuronal cultures. IMPACT: Our integrative, cross-species
approach will functionally dissect a promising transcriptional regulatory network using powerful, in vivo assays,
mapping the complex molecular architecture of AD excitotoxic neuronal injury and pinpointing vulnerable
nodes for pharmacologic reprogramming with potential to preserve synaptic health.

Public health relevance
NARRATIVE Alzheimer’s disease is a devastating and incurable neurodegenerative disorder projected to affect 13 million individuals in the US by 2050. Integrating recent advances from studies of large human brain autopsy collections with innovative model organism investigations, we will probe mechanisms and develop therapeutic approaches to modulate a promising gene network responsible for brain health in Alzheimer’s disease. An improved functional understanding of Alzheimer’s disease gene regulatory networks holds enormous potential for therapeutic breakthroughs.